Novel Multiple-Stage Active Antimalarials

PROJECT SUMMARY/ABSTRACT
Malaria has been a deadly enemy of mankind throughout history, currently affecting over 200 million people
annually along with approximately half a million deaths. Full or partial drug resistance to current therapies,
specifically quinolines, antifolates, artemisinin derivatives, and other artemisinin partner drugs, is of great
concern. The newly approved and implemented vaccine does not offer complete sterilizing immunity, hence
there is still an urgent need to strengthen the antimalarial drug pipeline through the discovery and development
of novel, affordable, effective, and well-tolerated multiple-stage active antimalarials that operate by new
mechanisms. This proposal is based upon an established collaboration between the Kancharla, Kelly, Roth
and Fidock laboratories focusing on the natural products inspired novel tambjamine antimalarials. A rigorous
optimization strategy has produced several multiple-stage active lead tambjamine candidates that exhibited
superior curative oral efficacy in different animal models while exhibiting good safety and metabolic profiles.
The objective of the current research proposal is to advance early leads identified in the previous funding
period into late-stage lead candidates with potential for future advancement to clinical trials. The principal goals
will be improving the pharmaceutical properties of the current leads, increasing in vivo efficacy, oral
bioavailability, and metabolic stability in murine models while decreasing toxicity, and investigating mode(s) of
action for the novel TA chemotype. Overall, the long-term objective of the proposed research is to develop a
novel, affordable, metabolically stable, orally bioavailable, effective and well-tolerated drug with broad-
spectrum activity against multiple-stages of malaria infection, which ultimately can be co-formulated with other
antimalarials in a synergistic combination to prevent and treat malaria, including radical cure in patients with
G6PD deficiency, thus supporting world-wide elimination of the disease.

Public health relevance
PROJECT NARRATIVE Malaria is estimated to cause over 200 million clinical cases and claim over 600,000 lives each year, mostly in children under the age of five, taking the life of a child every two minutes. Drug resistance to the current antimalarial therapies is growing at an alarming rate, hence there is an urgent need for novel, affordable, effective, and well-tolerated drugs with new modes of action for prevention and treatment of malaria. We have developed a novel antimalarial tambjamine chemotype that is potent against both blood stage and liver stage malaria parasites, with single-dose cure ability and potential to prevent relapsing infection, that warrant further preclinical development.